RECOMBINANT ENVELOPE PROTEINS OF HIV-1 GP160 AND GP120 IN HIV INFECTION

This study is designed to provide pilot data on the immunogenicity of each of the three candidate vaccines in asymptomatic HIV-infected children one month of age or older.